Maintenance of the Animal Feed Regulatory Program Standards (AFRPS) and the Development of Preventive Control Inspection Infrastructure by the Missouri Department of Agriculture, Bureau of Feed, Seed.

Project Summary
Maintenance of the Animal Feed Regulatory Program Standards (AFRPS) and the
Development of Preventive Control Inspection Infrastructure by the Missouri Department
of Agriculture, Bureau of Feed, Seed.
Since Missouri is home to a significant percentage of the nation’s livestock and pet food
production, the regulation of feed is of vital importance for the protection of livestock feed and
pet food consumers and producers. As evidenced by recent significant feed adulteration events,
feed is an important link to the human food supply and is therefore an important element of the
human food safety equation.
The Bureau of Feed & Seed (Bureau) has regulatory responsibility of livestock feed and pet
food sold, manufactured and distributed in Missouri. The Bureau operates under the authority of
the Director of the Missouri Department of Agriculture and within the Division of Plant Industries
and also operates the Missouri Feed Control Laboratory (Lab). The Laboratory analyzes 5,000
surveillance feed samples annually. The feeds represented by these samples are produced
both in Missouri and across the nation and are obtained by program inspectors on a weekly
basis from manufacturing, distributing and retail firms.
The Bureau considers the implementation and maintenance of AFRPS as an important step in
fulfilling its role as a crucial and significant partner with FDA in the protection of this state’s and
our nation’s food supply. The Bureau‘s intent is to utilize cooperative agreement funds to
continue to meet the critical needs of the feed program to maintain full implementation of the
Standards and develop additional infrastructure to reach the capacity and capability to inspect
the full inventory of Missouri feed facilities for compliance with the Preventive Control Rule for
Animal Feed.
The feed program expects to utilize FDA Cooperative Agreement funds to improve program
capability in the following ways: Maintain inspection strength to provide sufficient risk based
inspections, provide education & outreach to industry, ensure appropriate program staff training
levels, build compliance and enforcement infrastructure, and acquire and maintain technology to
improve program productivity and efficiency in regulatory processes.
The Bureau is committed to enhancing its cooperation and collaboration with the FDA and other
state feed control programs by sharing data, best practices and processes, software
development and actively promoting and advancing the improvement of human and animal food
safety in an effort to bring continuous improvement to the partnership for food protection.

Public health relevance
Project Narrative Maintenance of Missouri’s Conformance with the Animal Feed Program Standards (AFRPS) and Coordinating Missouri’s Preventive Control Activities (U18) PAR-20-132 of the Missouri Department of Agriculture will assist the FDA in providing feed/food safety not only for Missouri but other states, as Missouri provides a significant percentage of the nation’s livestock and pet food production. The regulation of feed is vital for the protection of livestock feed and pet food consumers and producers, as feed is an important link to the human food supply and therefore an important element of public health.